2023 Nitric Oxide GRC and GRS

PROJECT SUMMARY
This proposal requests partial support for a meeting on the “Molecular Mechanisms of Nitric Oxide Signaling in
Health and Disease” as a Gordon Research Conference (GRC) and Gordon Research Seminar (GRS) to be
held in Ventura California from February 12th -17th 2023. The broad and long-term goal of this conference is to
bring together the world's leading researchers in this field to foster cross-disciplinary discussions and
collaborations. The meeting is designed to enhance our understanding of Nitric Oxide as a regulator of
physiological function and as such an important target for control in both health and disease. In particular, we
are interested in emphasizing how restoring appropriate Nitric Oxide signaling can alleviate diseases as varied
as diabetes, hypertension, asthma, and COVID-19 related pneumonia. The 2023 conference will include a
GRS for trainees held immediately prior to and in conjunction with the GRC. The specific aims of this meeting
will be to convene over 35 leading experts who will present unpublished data and insights within the field of
Nitric Oxide research. The GRC program will be structured into 9 sessions that comprehensively cover the field
with sessions focused on cardiovascular performance, molecular mechanisms of signaling, Nitric Oxide
generation and detection, and the role of Nitric Oxide in respiratory health. Both basic and translational
research will be highlighted, with a major emphasis on physiological signaling and disruptions of this system
that can be targeted to improve human health. Afternoon poster sessions will permit all participants to
contribute to these topics with the most meritorious abstracts chosen by the conference Chair and Vice-Chair
for oral presentations. Every effort will be made to encourage participation by graduate students and
postdoctoral fellows in the GRC. In addition, the GRS will be specifically aimed at trainees, allowing them to
present their research and interact in a relaxing and extra supportive environment. Every effort will be made to
promote gender parity and include racial/ethnic minorities and persons with disabilities. The significance of this
application lies in the much needed forum provided by the GRC and GRS to bring together and synergize the
members of an international research community working on Nitric Oxide. Nitric Oxide research is unique in
that it brings together chemists, environmental scientists, pulmonary and cardiovascular physicians. The
Gordon conference on NO which has run since 1995 provides one of the only venues that brings together this
diverse group and promotes transformational research ideas. The GRS will have the added value of helping to
train and energize the next generation of researchers in the field. The need for greater understanding of how
Nitric Oxide is critical to normal human function has only been made more apparent in the recent COVID
pandemic. Nitric Oxide based detection and delivery systems are currently in use to not only treat patients, but
to improve general health levels and improve resistant to disease. The investigators brought together by this
conference have the potential to bring about true transformational change in human health.

Public health relevance
PROJECT NARRATIVE Nitric Oxide is a fundamentally important signaling molecule within human biology, whose mechanisms of action are still unclear. However, novel therapeutic advances utilizing Nitric Oxide chemistry are constantly being developed. The discussions of the current research at this Gordon Research Conference (GRC) and Gordon Research Seminar (GRS) will highlight recent advances and define important questions that need to be addressed for the development of new therapeutics but will also examine how restoring Nitric Oxide function can prevent disease.